Assessing the Dynamics of Hippocampal Neuronal Engrams in Memory Formation and Aging

PROJECT SUMMARY/ABSTRACT
Defining how we form, store, and retrieve memories is one of neuroscience’s most researched areas. The
hippocampus is a well-characterized forebrain structure with a crucial role in the formation and retrieval of
episodic memory, and is known to be vulnerable to age-related memory dysfunction. Cognitive decline in age
and neurodegenerative disease is an increasing burden on healthcare systems and society at large. To treat the
causes of memory decline in age and age-related disease, the mechanisms by which hippocampal cell
populations form and maintain individual memories over time must be characterized. Decades of research have
shown that new learning results in strengthened synaptic connections between networks of hippocampal
neurons. These distributed connections between cells are believed to make up the physical basis for memories,
often defined as an engram. Significant progress has been made in finding the engram in the brain with the
application of activity-dependent genetic strategies, which isolate populations of cells expressing immediate-
early genes (IEGs), to identify the neurons activated by learning. Subpopulations of neurons expressing the IEG
c-Fos are activated during learning and reactivated during memory recall, so they are often referred to as engram
neurons. Previous studies demonstrated the crucial role of hippocampal engram neurons in memory recall
behavior, and artificial reactivation of these cells in mouse models of aging and Alzheimer’s disease rescued
memory retrieval deficits, pointing to engram cells as a promising target for future interventions to treat memory
deficits. However, the in vivo mechanisms by which these cells store associations, and how their reactivation
drives memory retrieval, have yet to be explored. To address this gap in knowledge, this project will utilize novel
two-photon imaging to combine an inducible c-Fos tagging strategy with large-scale calcium imaging, to
investigate how these cell populations contribute to memory formation. Aim 1 of this project is to characterize
the dynamics of engram cell populations across learning in order to inform our understanding of circuit
mechanisms underlying memory formation in healthy states. This mechanistic understanding will then be utilized
in Aim 2 to define how these processes are negatively impacted by aging. Overall, the aims of this proposal will
contribute to the advancement of our understanding of the circuit mechanisms of hippocampal memory formation
in health and disease, with the potential to inform current treatment strategies for cognitive decline.

Public health relevance
PROJECT NARRATIVE Treatments for age-related memory decline rely on understanding the basic mechanisms of hippocampal memory formation and storage over time. The proposed experiments will investigate these mechanisms using a novel method combining two-photon imaging and activity-dependent genetic strategies to identify and track populations of neurons storing episodic memories in the hippocampus. The conclusions from these experiments will advance current models of associative memory formation, ultimately contributing to a circuit-level understanding of memory in order to provide targets for intervention in treatments for memory deficits in aging.